Lipid-dependent host-microbe interactions

PROJECT SUMMARY
Lipids serve as important mediators of host-microbe interactions yet many mechanisms that support signaling
through these interactions have yet to be characterized. Of special interest are classes of lipids that have well-
defined signaling pathways in host systems but have less well understood synthesis pathways in microbial
systems. My research program has focused on defining how a class of lipids, the sphingolipids, can mediate
interkingdom host-microbe interactions through the functions of these lipids as structural components of
membranes and as chemical signals. To understand the importance of sphingolipids to host-microbe
interactions, we have developed techniques to trace sphingolipid transfer through these interactions. These
efforts have alerted to us to under characterized pathways in microbial sphingolipid metabolism that we have
been able to profile and manipulate to deepen our understanding of the importance of microbial sphingolipid
metabolism to host-microbe interactions. We have integrated techniques in microbial genetics, biochemistry,
flow cytometry, high-throughput sequencing, and liquid chromatography-mass spectrometry to define host-
microbe sphingolipid transfer and characterize key microbial sphingolipid metabolism genes. Our innovations
in investigating sphingolipid-dependent host-microbe systems have the potential to accelerate discovery in a
range of host-microbe systems and for a wide range of metabolites. To capitalize on this potential, we have
used our workflows to investigate new ways that cholesterol mediates host-microbe interactions and propose
to expand to other classes of bioactive lipids. The goals for the next five years of the research program are to
use techniques developed from our investigations into sphingolipid-dependent host-microbe interactions to
accelerate knowledge of how the important lipid classes of sphingolipids, cholesterol, and fatty acids mediate
host-microbe interactions. For sphingolipid-dependent host-microbe interactions, we plan to further define
genes contributing to bacterial sphingolipid metabolism and determine how this gene activity may generate
bioactive signaling molecules with relevance to prominent host cellular receptors. For cholesterol-dependent
host-microbe interactions, we plan to further define microbial metabolites produced from exogenous
cholesterol and expand on investigations into how microbial cholesterol sulfotransferase activity regulates
microbial and host phenotypes. For fatty-acid dependent microbe interactions, we plan to define the microbes
that interact with distinct saturated and unsaturated fatty acids as well as the potential suite of bioactive
metabolites produced from these interactions. Together, these efforts will deepen our knowledge on how lipids
mediate host-microbe interactions at a level that can inform microbiome-centric therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Lipids are important mediators of signaling with underdefined roles in mediating communication between mammals and their beneficial gut microbes. Defining key mechanisms governing host-microbe lipid exchange will allow us to target these exchanges for the benefit of human health.